Microglia- Astrocyte Crosstalk in Cortical Neurodegeneration of C9orf72 ALS/FTD

PROJECT ABSTRACT
Amyotrophic Lateral Sclerosis (ALS) is a progressive neurodegenerative disease
characterized by loss of spinal cord and cortical motor neurons, and frontotemporal dementia
(FTD) is an early-onset dementia syndrome caused by the degeneration of the frontal and
temporal lobes. The most common genetic cause of both these diseases is the GGGGCC(G4C2)
hexanucleotide repeat expansion (HRE) in the first intron of the C9orf72. Much of the
knowledge in C9orf72-ALS/FTD disease pathogenesis thus far has come through investigations
of neuronal disease mechanisms. Despite the large evidence of the active involvement of glial
cells in neurodegeneration, little is known about the specific mechanisms. One question that
remains unanswered is whether a glia-glia interaction is required to initiate neurodegeneration,
or do astrocytes and microglia independently contribute to this process? We have shown an
altered expression profile of microglia and astrocytes in the frontal cortex of C9orf72 ALS/FTD
patients. Additionally, in our iPSC modeling system we have seen aberrant expression of the
NLRP3 inflammasome in microglia and astrocytes. These findings lead to the following
hypothesis: microglia- astrocyte crosstalk underlies a chronic pro-inflammatory state in
C9orf72 ALS/FTD. To investigate this knowledge gap, we will utilize state of the art human in
vitro culture systems, which offer opportunities for easy cell-type specific manipulations and
analyses while working with human patient-derived cells. We will utilize mono-culture systems to
assess morphological, functional, RNA, and protein changes. We will validate our in vitro
findings using ALS/FTD patient brain tissues on both the RNA and protein levels with the intent
of understanding the cell-to-cell regulatory mechanisms of glia and their contribution to disease
pathology. These studies will provide novel molecular targets and biomarkers of disease.

Public health relevance
Project Narrative A mutation in the C9orf72 gene represents the most common genetic variant in amyotrophic lateral sclerosis (ALS) and frontotemporal dementia (FTD), which encompasses a disease continuum characterized by concurrent degeneration of cortical and spinal motor neurons. Our studies are aimed at understanding the contribution of the crosstalk between microglia and astrocytes to this neurodegeneration, and the contribution of sex to this crosstalk. The results will facilitate the identification of novel molecular targets and biomarkers of disease.